The role of pattern recognition and autophagy in innate anti-bunyaviral immunity

Summary
Innate immunity is the first line of defense against pathogens and is highly conserved from insects to
humans. While many key facets of the innate immune system have been elucidated, there is a fundamental gap
in our knowledge of the pathways that restrict arthropod-borne viral infections in the diverse target tissues that
are infected during the infection of the mammalian host. Importantly, a molecular understanding of these
mechanisms is essential to overcome the lack of effective antiviral therapeutics and combat human disease.
The Drosophila immune response is highly homologous to that of vector insects and additionally shares striking
similarities with mammalian innate immunity. Using the Drosophila system, we previously found that the
emerging bunyavirus Rift Valley Fever virus (RVFV) is sensed by the Drosophila Pattern recognition receptor
(PRR), Toll-7, which activates antiviral autophagy and that this is conserved in mammalian cells. We found that
TLR2-dependent antiviral autophagy can control RVFV in some cell types while in other cells engagement of
TLR2 leads to cell death. Moreover, we found that pharmacological activation of autophagy is restrictive against
RVFV in mammalian primary neurons, suggesting that this pathway may be harnessed for antiviral protection.
Since tissue-specific signaling of PRR pathways are poorly characterized we screened a panel of PRR agonists
for those that could block RVFV infection in neurons and in non-neuronal cells in parallel. We identified two
classes of antiviral PAMPs. First, we identified TLR2 agonists as antiviral in both cell types. Since
pharmacological activation of autophagy can protect primary mammalian neurons from infection, we suggest
that TLR2 activation may be harnessed to defend neurons from encephalitic viruses. Second, we identified
Dectin-1 agonists as specifically antiviral in neurons which will be further explored. Therefore, the long-term
objective of the proposed research is to understand the molecular mechanisms by which viral infections
are sensed and controlled by innate pathways and how this may be harnessed to induce protective
defenses in diverse cell types including neurons. To accomplish these goals, this application proposes two
specific aims: (1) to identify the mechanism by which RVFV is sensed by TLR2 leading to diverse outcomes,
autophagy or cell death; and (2) explore the PRR pathways that can control bunyaviruses in mature mammalian
neurons.

Public health relevance
Narrative Due to the dearth of antiviral therapeutics, there is an urgent need for the discovery of novel mechanisms by which we can overcome viral pathogens. This project focuses on the understanding pattern recognition receptors and autophagy as essential and conserved components of antiviral defense against emerging viruses, focusing on bunyaviruses, that are transmitted to humans from vector insects. These viruses are encephalitic and we have identified additional innate signaling pathways that can control infection in primary mammalian neurons and thus we will also reveal new strategies for interventions in neurons which are poorly understood.